Introducing Young Children to Biomedical Science with a Screenless Interactive Device (infinibook)

Parents and educators face significant challenges in delivering early STEM and biomedical education
effectively. A major obstacle is the lack of engaging and age-appropriate screen-free resources for young
learners who are still learning to read. Most educational content available is geared towards older children and
adults, with complex language and concepts that are not accessible to preschoolers or early primary students.
Cali’s Books’ solution, the infinibook platform, represents a transformative leap in educational technology by
integrating advanced digital features into a traditional book format, combining the tactile comfort and cognitive
benefits of physical books with the interactivity of modern digital tools. This innovation seamlessly merges
hardware and software to deliver a unique, engaging, personalized learning experience for young children. In
the NIH SBIR project, “Introducing Young Children to Biomedical Science with a Screenless Interactive Device
(infinibook),” the team will develop and launch the interactive "Smarty Cats" biomedical book series, aiming to
get these books into the hands of as many children aged 4 to 7 as possible, both at home and in schools. The
Fast-Track project aims to disseminate biomedical knowledge and spark an early interest in science, fostering
future vocations in the biomedical field. "Smarty Cats" is designed to teach biomedical science concepts
through humor, engaging storytelling, and interactive games and activities. The infinibook will use artificial
intelligence to learn a user’s level and personalize “Smarty Cats” audio content to ensure the material is
engaging and appropriate for users’ age and development stage. The Phase I goal is to develop the first
“Smarty Cats” book and examine the appropriateness of the content, the user experience, and its success at
engaging students from pre-kindergarten through first grade. In Phase II, we will continue with technology
improvements to prepare the Smarty Cats infinibooklet and the interactive infinibook platform for a larger
Phase II study and commercialization. We will integrate learnings from Phase I into the first Smarty Cats book,
iteratively develop the following three books in the series, examine the content validity and prototype usability
with preK-1st grade students in a teacher usability test, and conduct a large-scale pre-post trial to assess the
potential impact of the Smarty Cats infinibooklet prototypes and learning activities on student outcomes in
pre-K-1st grade classrooms. Upon successfully completing Phase II, CB will have developed biomedical
content suitable for early education and the framework to continue producing a wide range of STEM content for
the infinibook for future commercial release. The solution will provide a screen-free, personalized tactile
learning experience that promotes cognitive development without the drawbacks of excessive screen time. By
promoting early health literacy and scientific curiosity, the “Smarty Cats” books and infinibook platform can
enhance individual learning experiences, contribute to broader societal goals of improved health awareness
and scientific engagement in young children, and inspire future generations of healthcare professionals.

Public health relevance
Project Narrative Early biomedical science education can promote healthy behaviors and cognitive development and lay the groundwork for sustained interest in science, but existing educational resources target older users and can pose risks for young children, including excessive screen time and inappropriately complex content. The “Smarty Cats” series for Cali’s Books’ infinibook solution represents a transformative leap in educational technology by integrating advanced digital features into a traditional book format, combining the tactile comfort and cognitive benefits of physical books with the interactivity of modern digital tools. The holistic approach to early biomedical education will enhance individual learning experiences and contribute to broader societal goals of improved health awareness and scientific engagement in young children.